HYBRIDOMA ANTIBODIES TO PATHOGENIC VIRUSES

Production and characterization of monoclonal antibodies to hepatitis A virus are in progress. The development of new serologic tests for detection of monoclonel anti-HAV has simplified the procedure. Five specific monoclonal antibodies have been produced and are being analyzed.